Sex Differences in Postprandial Lipid Metabolism

The high levels of saturated fat in Western diets contribute to the risk for obesity, diabetes and cardiovascular
disease. Consumption of a fat-rich mean triggers a surge in circulating triglyceride TG levels as well as an
inflammatory response that last several hours. As a result, we may spend a majority of our waking hours in a
postprandial state. Non-fasting/postprandial TG levels are an independent predictor for cardiovascular disease.
Studies in humans of multiple ethnic groups, as well as in the mouse, indicate that biological sex is a key
determinant of postprandial hyperlipidemia, with males experiencing higher postprandial TG levels and
inflammatory response. Knowledge gaps remain in our understanding of the physiological and molecular
processes that differ between males and females to influence postprandial lipid handling and inflammation.
Furthermore, the components of biological sex (which include ovarian and testicular hormones as well as genetic
sex determinants, the XX and XY sex chromosomes) have not been systematically investigated with respect to
postprandial metabolism. Our preliminary studies indicate that a lipid meal leads to substantially higher and more
persistent circulating TG levels in males compared to females regardless of time of meal administration (i.e.,
during a typical fasting or feeding period) or presence of gut microbiota (the sex difference persists in gnotobiotic
mice). Male mice also experience an enhanced postprandial inflammatory response, characterized by increased
circulating monocyte number and inflammatory gene expression in bone marrow cells. Preliminary mechanistic
studies indicate that rates of postprandial lipoprotein appearance in the circulation are similar in males and
females, but that lipid composition and lipolysis differ. Our studies in the Four Core Genotypes mouse model
reveal that the sex difference in postprandial hypertriglyceridemia is associated with gonadal sex (levels correlate
with presence of ovaries vs. testes), whereas postprandial LPS levels are associated with sex chromosomes
(presence of XX vs. XY). We propose to identify physiological and sex-related mechanisms that drive differences
in postprandial lipid metabolism between males and females. Aim 1: Identify the metabolic processes and
bioactive lipid components that promote male-biased postprandial hypertriglyceridemia and
inflammation. We will perform in vivo and ex vivo studies in male and female mice to identify the mechanisms
that lead to sex-biases in postprandial lipid composition, lipolysis, and inflammatory activation. Aim 2: Elucidate
the control of postprandial lipid metabolism and inflammation by gonadal sex and chromosomal sex.
Our studies in Four Core Genotypes mice revealed that distinct sex components influence postprandial lipid
levels and inflammation. We will test the hypotheses that estradiol and/or testosterone regulate postprandial TG
levels (using gonadectomized mice and hormone replacement), whereas the sex chromosome complement is a
determinant of postprandial endotoxemia and inflammatory responses (using the XY* mouse model to compare
animals with XX, XY, XO and XXY chromosome complements).

Public health relevance
Project Narrative Habitual consumption of a high-fat diet is a risk factor for diabetes and cardiovascular disease. Eating a fat-rich meal triggers a surge in blood lipids and inflammatory cells that can last for several hours. We aim to understand why a fatty meal has different effects in males and females, which may inform about the optimal preventive and therapeutic measures that should be taken for cardiometabolic disease in men and women.